A Consortium for Gut-Brain Communication in Parkinson's Disease

Project Summary/Abstract
We plan to additionally support the initial participation and conduct in the NIH U01 Consortium for Gut-Brain
Communication in Parkinson’s Disease (PD) (GBPDC) including contribution of PD patients across the
spectrum of disease, with and without GI symptoms and age/sex matched healthy controls into the registry.
The patients will be phenotyped with in depth Parkinson’s and GI measures including clinical symptoms and
physiologyData from the entire registry cohort will also be analyzed to assess to the relationships between PD
dysfunction and gut motility.

Public health relevance
Project Narrative We plan to additionally the initiation and conduct of the NIH U01 Consortium for Gut-Brain Communication in Parkinson’s Disease (GBPDC) including contribution of patients into the where they will be phenotyped with in depth Parkinson’s and GI measures including clinical symptoms and physiology.